Engineering an extracellular vesicle-based targeted regenerative nanotherapeutic for multiple sclerosis

ABSTRACT
Multiple sclerosis (MS) is an autoimmune disease that gives rise to chronic neurological deficits. It is caused by
an immunological attack on the myelin sheath leading to demyelination and axon degeneration. MS is the most
common demyelinating disease of the CNS in young adults. 8,000-10,000 children and approximately 1 million
adults are currently diagnosed with MS in the US. Furthermore, most MS cases result in frequent relapses.
Currently available treatments can diminish the incidence of acute flare-ups, but do not prevent progressive
axonal degeneration and neurological disability. Mesenchymal stem/stromal cells (MSCs) and MSC-derived
extracellular vesicles (EVs) have been suggested as a promising approach for the treatment of MS, since MSCs
and MCS-EVs can confer multifactorial therapeutic functions such as immunomodulation, neuroprotection, and
angiogenesis. Our lab has established methods to isolate and expand early gestational placenta-derived MSCs
(PMSCs) and demonstrated that compared with adult tissue-derived MSCs, PMSCs and PMSC-EVs possess
superior immunomodulatory, neuroprotective and pro-angiogenic functions. In a preliminary study, we confirmed
PMSC-EVs promoted re-myelination through the differentiation of oligodendrocyte precursor cells (OPCs) into
mature oligodendrocytes and improved motor function outcomes in an experimental autoimmune
Encephalomyelitis (EAE) mouse model of MS. One major obstacle of effective clinical application of EVs is the
lack of disease-specific targeting efficiency to the sites of injury, especially to the CNS. It is well known that
integrin a4ß1 is highly expressed by multiple pathogenic lymphocytes and mediates inflammatory cell homing
into the CNS in MS. Currently, therapies targeting integrin a4ß1 have been used as a treatment for adult MS.
Using ultra-high throughput one-bead one-compound (OBOC) combinatorial screening, we identified LLP2A as
a high-affinity (IC50~2pM) and high-specificity targeting ligand against activated a4ß1 integrin. Furthermore, we
showed that LLP2A is an a4ß1 integrin antagonist and can decrease inflammation. The overall goal of this
proposal is to develop a new multi-component, multi-functional, EV based nanotherapeutic with improved
targeting efficiency for MS. The treatment is comprised of unique PMSC-EVs that will be further engineered by
surface modification with targeting ligand LLP2A. In this application, we hypothesize that conjugation of LLP2A
onto the surface of PMSC-EVs (LLP2A-PMSC-EVs) can facilitate the targeting of PMSC-EVs to multiple
activated pathogenic immune cell subsets, thus improving PMSC-EV targeting efficiency, tissue distribution, and
ultimately therapeutic efficacy. We will leverage our lab’s established state-of-the-art bulk and single-EV
characterization methods to evaluate ligand conjugation efficacy on EVs. The central objective of this study is to
develop an effective approach to modify PMSC-EVs with LLP2A to efficiently target and modulate pathogenic
lymphocytes to promote neuroprotection and remyelination. This study will facilitate future investigations into
finding a novel bioengineering approach of stem cell-derived and cell-free regenerative therapy for MS.

Public health relevance
PROJECT NARRATIVE Multiple sclerosis is a debilitating disease caused by autoreactive immune responses that lead to demyelination and results in loss of neurologic function. Currently available medications address the inflammatory component of the disease but do not prevent progressive degeneration of neurons. This study will develop a new multi- component, multi-functional, nanotherapeutic with improved targeting efficiency and therapeutic function for MS.